Black Girls Move: A Daughter/Mother Intervention to Prevent Obesity by Increasing Physical Activity and Improving Dietary Intake among Black Adolescent Daughters

Project Summary/Abstract
Black female adolescents are at increased risk for obesity-related morbidity and mortality as adults compared to
non-Hispanic White female adolescents. Interventions to prevent obesity in Black female adolescents that
leverage the relationship of the daughter/mother dyad have received limited attention. Studies that do include
mothers tend to use theoretical frameworks that do not explicitly build on this important family relationship and
have not included mothers’ active participation. Additionally, these studies do not include girls over the age of
12. In response, we developed Black Girls Move, a school-based obesity prevention intervention that
addresses these limitations in the extant literature. We conducted focus groups with daughter/mother dyads to
identify practical, cultural, and age-appropriate strategies for improving physical activity (PA) and dietary
behaviors in Black adolescent daughters (grades 9-10, ages 14-17). Black Girls Move consists of 12 weekly
group sessions of daughter/mother dyads in which participants set individualized PA and dietary goals. Black
Girls Move incorporates content and processes derived from asset-based anti-racist Public Health Critical
Race Praxis, Family Systems Theory, and Social Cognitive Theory. Specific aims are to determine the
efficacy of Black Girls Move compared to daughters-only comparison condition on change in PA and dietary
intake, and the impact of Black Girls Move compared to daughters-only on theoretical mechanisms of change
(racial identity, daughter/mother relationship, social cognitions) assessed by self-report measures.
The design is a 12-week pre-test/post-test, randomized controlled trial. We will recruit 24 daughter/mother
dyads at each of 8 schools for a total sample size of 192 daughter/mother dyads. Within school, each dyad will
be randomized to either Black Girls Move or daughters-only comparison condition (12 per condition). All
daughters and all mothers (Black Girls Move daughter/mother dyads and daughters-only comparison condition
daughter/mother dyads) complete assessments (e.g., PA, diet, family measures) at baseline, post-intervention,
and 3-months post-intervention. We recognize that there are potential validity threats associated with within-
school student randomization. We will collect data to assess the degree to which these potential threats are
pertinent. The long-term goal of this research is to decrease disparities in obesity and associated co-
morbidities in Black women. The findings may inform future large scale R01 studies of BGM in Black
daughter/mother dyads.

Public health relevance
Project Narrative We propose to test Black Girls Move, a school-linked daughter/mother physical activity and dietary behavior program, with 9th and 10th grade students. This program is designed to prevent obesity in Black adolescent females and thus aligns with the NIH mission to enhance health, lengthen life, and reduce illness and disability. This project is relevant to public health because it holds the potential to reduce population health disparities impacted by structural racism.